UV RADIATION ON SYNTHESIS AND DEGRADATION OF VITAMIN D3

The purpose of this study is to determine the effect of exposure to simulated sunlight on the vitamin D nutrition status in healthy adult volunteers.